OPIODS IN NORMAL MENSTRUAL CYCLE AND IN POLYSYSTIC OVARY DISEASE

To investigate the role of hypothalamic beta endorphins in the regulation of the midcycle gonadotrophin surge in normal women as compared to patients with polycystic ovarian disease; and to determine if patients with PCOD have an abnormality in the pituitary of beta endorphins or other derived peptides.